Development of a highly sensitive and specific POCT testing asthma triggering allergic IgE

Abstract
The overall goal of this project is to develop and eventually commercialize a novel point-of-care test capable
of rapidly and highly accurately detecting allergic IgE to environmental allergens as an approach to promote
healthy living and reduce minority health disparities. The burden of asthma in the US falls disproportionately on
Black, Hispanic and American Indian/Native Alaskans/Asians. These minority groups have the highest asthma
rates, deaths and hospitalizations. IgE-mediated allergic asthma is the major type of asthma, consisting of ~75%
of all the asthmas. The most relevant allergens triggering IgE-mediated allergic asthma are environmental
allergens that disproportionately impact the socioeconomically disadvantaged population and minorities due to
their relatively constraint living conditions, lower available resources and limited access to healthcare, leading to
the existing health disparities. Therefore, a more accurate, convenient, low-cost, rapid and point-of-care
enabled IgE test capable of rapidly and accurately identifying allergic IgE by overcoming false positivity of the
current IgE tests would be a key component in efforts to enhance healthy living and reduce minority health
disparities, but such a point-of-care enabled IgE test is not currently available and yet to be developed. Under
such background we propose to develop a novel IgE testing approach capable of rapidly and accurately detecting
allergic IgE against the common allergens associated with allergic asthma triggering to address the health
disparity issue, using Allerdia’s proprietary Reverse Lateral Flow ImmunoAssay (R-LFIA) technology platform.
In Aim 1, we will individually establish a simplex format of R-LFIA testing IgE commonly associated with asthma
triggering by developing R-LFIA testing IgE specific for allergens of cat, dog, house-dust mite, cockroach,
common pollen, birch, and selected molds (Penicillium notatum, Aspergillus fumigatus, Cladosporium herbarum,
and Alternaria alternata) with high test sensitivity and specificity. In Aim 2, we will develop a point-of-care
enabled rapid test device with multiplex capacity to simultaneously detect allergic IgE responsible for triggering
of allergic asthmas using single sample. Accomplishment of the proposed Aims will pave the way for a
prospective clinical investigation and application of this novel IgE testing in determining the responsible
environmental allergen-specific IgE triggering allergic asthma in a rapid fashion with point-of-care capacity.

Public health relevance
Narrative The burden of asthma in the US falls disproportionately on Black, Hispanic and American Indian/Native Alaskans/Asians, as these minority groups have the highest asthma rates, deaths and hospitalizations. Among 25 million American asthmatics, IgE-mediated allergic asthma is the major type that impacts ~75% of all the asthmatics. The most relevant allergens triggering IgE-mediated allergic asthma are environmental allergens. However, all the currently available centralized IgE tests have the common problem of high false positivity that greatly impacts the underserved minorities, leading to the health disparities. Therefore, a more accurate, convenient, low-cost, rapid and point-of-care enabled IgE test capable of rapidly and accurately identifying allergic IgE by overcoming false positivity of the current IgE tests would be a key component in efforts to enhance healthy living and reduce minority health disparities. Under such background the proposal of developing a novel IgE testing approach capable of rapidly and accurately detecting allergic IgE with point-of-care test capacity to address the health disparity issue using Allerdia’s proprietary Reverse Lateral Flow ImmunoAssay technology platform is of high clinical significance.